CHIME Administrative Core (AC)

Project Summary for the RCMAR CHIME Administrative Core
The goal of RCMAR is to improve the health of older minority populations by mentoring and developing highly
skilled minority faculty whose passion and careers are devoted to reducing health disparities for the most
vulnerable older adults in our country. The Administrative Core (AC) will provide the leadership needed to keep
the center focused on addressing the theme of “Developing, Adapting and Evaluating Interventions to Improve
the Health of Minority Elders”, which incorporates elements of two of the RFA areas of scientific focus: i)
research aimed at understanding and modifying organizational or individual behaviors associated with health
outcomes in later life, and ii) research on factors that affect population aging and its consequences. The
proposed AC for the UCLA CHIME competitive renewal application has 9 specific aims: 1) To provide
intellectual leadership and ensure that the UCLA RCMAR's scientific focus is maintained, 2) To provide
operational management and close financial oversight of UCLA CHIME, 3) To ensure the RCMAR scientists,
researchers and mentors interact seamlessly with colleagues, maintaining information flow, 4) To ensure the
continued recruitment and retention of investigators from underrepresented backgrounds (RCMAR Scientists)
and the viability of mentoring and training relationships among affiliated institutions, 5) To oversee the annual
selection of pilot studies that address CHIME's theme and facilitate linkage to other existing NIA- or NIH-
funded Centers or funded projects with the appropriate mentors for the content area of interest, and to submit
the recommended pilot studies to NIA Project Officers for approval, 6) To complete the CHIME semi-annual
report, presenting CHIME's scientific results as contributions to the state of the science, health policy, and
health practices that can improve the health of minority elders, 7) To organize scheduled External Advisory
Group meeting and Community Action Board meetings, 8) To assist with Institutional Review Board
submissions for all pilot studies and to assist with community-based recruitment and retention of minority
elders, 9) To evaluate curricular activities, pilot studies, and track whether RCMAR Scientists are advancing on
an appropriate trajectory toward independently funded research careers.